Interrogating the Fgl2-FcγRIIB axis on CD8+ T cells: A novel mechanism mediating apoptosis of tumor-specific memory CD8+ T cells

PROJECT SUMMARY:
One in fifty Americans will be diagnosed with melanoma in their lifetime and skin cutaneous melanoma is the
deadliest skin cancer. Cancer immunotherapy is a breakthrough approach to treat this disease and cytotoxic
CD8+ T-cell tumor infiltration is a critical factor to immunotherapeutic success. As such, identifying effective
strategies to increase the magnitude and functionality of the patient’s tumor-specific CD8+ T-cell response
remains an important goal. Inhibitory molecules on CD8+ T cells are imperative to T-cell signaling and immune
homeostasis. However, elevated expression of these molecules is correlated with dampened antitumor effector
response as well as poorer patient survival. FcγRIIB is an inhibitory Fc receptor recently discovered on a subset
of CD8+ T cells. FcγRIIB+ CD8+ T cells exhibit increased expression of activation markers, higher proliferative
ability, and secrete more proinflammatory cytokines than their FcγRIIB- counterparts in mice and humans,
making them imperative to the antitumor response. Recently, we discovered that an immunosuppressive
cytokine, fibrinogen-like protein 2 (Fgl2), is a ligand that binds FcγRIIB on CD8+ T cells and induces FcγRIIB-
mediated apoptosis of CD8+ T cells. The goal of this research is to interrogate the mechanism by which Fgl2
regulates tumor-specific FcγRIIB+ CD8+ T cells using syngeneic mouse models via the following aims. AIM 1:
Determine the cellular source of Fgl2 that critically regulates tumor-specific CD8+ T cells. Our studies
show that both Foxp3+ regulatory T cells and CD8+ T cells express Fgl2 at the tumors of mice and humans. Thus,
we will determine if Fgl2 secreted by these cell types is necessary and/or sufficient for FcγRIIB-mediated CD8+
T-cell apoptosis, findings which would provide the impetus for subsequent therapeutic targeting of this cell type.
AIM 2: Elucidate the mechanism by which the CD8+ T-cell isoform of FcγRIIB induces apoptosis upon
ligand binding by Fgl2. Our studies show that CD8+ T cells express a distinct isoform of FcγRIIB that can be
bound by Fgl2, but the immediate signaling events after Fgl2-FcγRIIB binding remain unknown. We will identify
proteins associated with the intracellular domain of FcγRIIB, specifically after ligand binding by Fgl2. This project
is in the context of melanoma as therapeutic success is heavily influenced by CD8+ T-cell infiltration, but the
impact of these findings could be applied to other immunologically “hot” tumors where immunotherapies are
gaining momentum. Our possession of several mouse models and unique expertise on the role of FcγRIIB in
CD8+ T-cell responses uniquely qualify us to address the proposed aims. The impact of the proposed aims is
considerable as they will identify novel targets, that when blocked, could rescue a population of memory CD8+ T
cells that are crucial to the immune response to tumor. Then, these “rescued” cells would unleash their effector
function to improve melanoma patient response. As CD8+ T-cell inhibitory molecules and immunosuppressive
cytokines negatively impact CD8+ T-cell infiltration, studying these interactions are of paramount importance as
we enter an era of cancer immunotherapy- a treatment dependent on the patient CD8+ T-cell response.

Public health relevance
PROJECT NARRATIVE: CD8+ T cells are crucial immune cells in our body’s fight against cancer and the degree to which CD8+ T cells traffic to and infiltrate the tumor greatly impacts cancer patient survival, especially melanoma patient survival. This project investigates a new pathway existing between CD8+ T cells and a protein present at the tumor that negatively impacts CD8+ T-cell survival. Through our mouse models, we will illuminate this mechanism to be able to block this negative interaction between CD8+ T cells and this suppressive protein to increase CD8+ T-cell survival, and ultimately improve melanoma patient survival.